Medical University of South Carolina Mentoring Program in Digestive and Liver Diseases

Abstract – Mentorship in digestive disease research areas is lacking. The reasons for this are complex, and have been attributed to a variety of factors. However, we have recognized that a major issue is the lack of effective mentorship. The overall objective of the Medical University of South Carolina (MUSC) contribution to the Helping to Accelerate Research Potential (HARP) Program in NIDDK related disease areas is to provide ready access to quality mentoring and training - thereby enabling outstanding research in NIDDK related disease areas. Our vision is to establish the HARP program as a sustainable resource for NIDDK related disease areas throughout the U.S. Through the HARP Program in Digestive and Liver Disease, we have hypothesized that a mentoring network to supplement that which is present in the mentee's university will provide additional critical and valuable mentorship. Therefore, we propose to implement innovative and transformative researcher mentorship and training to ensure development and sustainability of the digestive and liver disease workforce. We have proposed the 3 Specific Aims as follows: Aim 1 - to establish durable mentoring relationships and to effectively mentor a cadre of talented early career scientists to become independently funded in NIDDK related research areas through an integrated and dynamic mentorship program. Aim 2 - Increase scholars' scientific knowledge, professional skills, motivation, and credentials to pursue independent careers in NIDDK-related research areas via a rigorous educational and didactic program. Aim 3 – to promote the long-term viability and success of the HARP Program in NIDDK related research areas through rigorous evaluation, ongoing improvement strategies, and mission alignment with other HARP mentors and centers. The MUSC HARP program will be supported not only by MUSC's CTSA, but also by its rich and experienced institutional training programs. In summary, through expansion of mentorship of junior investigators and promotion of interdisciplinary exchange among mentors, Scholar's, and NIDDK leadership, the MUSC HARP Program will substantially augment thematic NIDDK related disease research on a national level. The founding efforts proposed here and in collaboration with the entire HARP group are expected to establish an effective, high quality, sustainable, and multidisciplinary career development program.

Public health relevance
Project Narrative – The MUSC HARP Program promises to support the career development of talented junior investigators and to promote of interdisciplinary exchange among mentors, these junior investigators, and NIDDK leadership. The MUSC HARP Program in NIDDK related disease areas will substantially augment thematic NIDDK related disease research on a national level. The founding efforts proposed here and in collaboration with the entire HARP group are expected to establish an effective, sustainable, and multidisciplinary career development program.